COG SDMC - Data Management Core

PROJECT SUMMARY / ABSTRACT
This is the Data Management Core to support the overall application for the Children's Oncology Group Statistics
and Data Management Center.